Region-Specific, Inducible Axonal Tract-Tracing in the Brain

Project Summary/Abstract
How neural circuits control complex behaviors is a fundamental problem in neuroscience. Optogenetic
tools have transformed our ability to identify genetically marked neuronal subpopulations of interest (NSOIs),
which serve as “points-of-entry” to behaviorally relevant circuits. However, a gap remains between the
identification of such NSOIs, and the ability to identify and map their downstream target neurons (DTNs);
identification of such DTNs is a crucial step in further tracing the circuit. To fill this gap, we will combine
optogenetic stimulation of NSOIs with single-cell RNA sequencing (scRNAseq), automated immediate early
gene (IEG) mapping, anatomical tracing and electrophysiology in candidate downstream target regions
(CDTRs), to identify DTNs of NSOIs in the ventromedial hypothalamus (VMH), which controls aggression,
defense and other emotional behaviors. The long-term goal is to elucidate the neural circuits that control
decisions between complex social and defensive behaviors. The overall objective of this application is to
develop a general approach for identifying and functionally characterizing DTNs of any NSOI of interest. Proof-
of-principle for these methods will be obtained by applying them to NSOIs in VMH which have previously been
shown to robustly control social and defensive behaviors. Preliminary studies have revealed that optogenetic
stimulation of estrogen receptor-1 (Esr1)-expressing neurons in VMHvl in solitary animals can be used to map
candidate DTNs throughout the brain, using serial-2-photon tomographic analysis of c-fos expression. This
approach will be used to identify candidate DTNs, using scRNAseq and activity-dependent marking systems.
The central objective of this proposal is to molecularly identify, and determine the behavioral function, and
downstream connectivity, of DTNs to which VMHvlEsr1 neurons (and other behaviorally relevant VMH NSOIs)
project. The rationale for this research is that solving this general problem is essential to making forward
progress in mapping the circuitry that governs complex behaviors. In Aim 1, we will develop an approach for
unbiased brain-wide mapping of DTNs activated by optogenetic stimulation of a genetically defined NSOI. In
Aim 2, we will develop and apply a new method, opto-Act-seq, to transcriptomically identify activated DTNs in
CDTRs. In Aim 3, we will identify projection DTNs (DTN-PNs) that are monosynaptic targets of the NSOIs,
using the novel methods “opto-TRACM” and “CRACM/TRACM-guided Patch-seq”. In Aim IV, we will determine
the functional role of DTN-PNs in social behaviors using “multiplex opto-TRACM.” The contribution will be to
develop a new approach to identify functionally and behaviorally relevant downstream targets of NSOIs in a
systematic, brain-wide manner. This contribution is significant because it allows unbiased, global mapping of
downstream circuits activated by a given NSOI. The approach is innovative, because it will develop novel tools,
and apply them to a behaviorally important circuit. The work proposed in this application will, therefore, both
advance knowledge in this specific field, and will also provide tools for investigators study other circuits.

Public health relevance
Project Narrative The proposed research is relevant to public health because our ability to diagnose and treat brain disorders is currently limited by our understanding of the fundamental neurobiological mechanisms underlying complex behaviors, and associated brain states such as motivation and arousal. Because of the evolutionary conservation of mammalian brain structures, an understanding of the neural circuitry controlling these processes in the laboratory mouse should yield fundamental concepts and details that are relevant to understanding the human brain. The research described in this proposal will develop innovative new tools that will aid in the functional dissection of neural circuit mechanisms, and is therefore relevant to NIMH's mission of achieving a deeper understanding of fundamental neurobiology and its dysfunction in brain disorders.